Critical Research Issues in Latinx Mental Health/American Society of Hispanic Psychiatry

Project Summary
The Hispanic population in the US is about 60.5 million and comprise 18% of the total US population.
Unfortunately, there number of Hispanic/Latinx Psychiatrists, Psychologists and Social Workers is significantly
less in proportion to non-Hispanic practitioners, with Hispanic physicians representing only 7% of the total
physician workforce. In the mental health field, Hispanic psychiatrists represent 5.8% of the psychiatrist
workforce, whereas Hispanic psychologist represent 5% and Hispanic social workers 14% of their
corresponding workforce. Numbers are similar in the research workforce with only 6% of all NIH funds being
awarded to Hispanic investigators. To mitigate this underrepresentation of Hispanic/Latinx investigators
interested in mental health, we propose to partner with the American Society of Hispanic Psychiatry (ASHP) to
enhance their annual meeting with a personalized and highly focused mentoring program. This mentoring
program will take place annually over one and a half days, in which 12 junior Hispanic/Latinx investigators will
be competitively selected out of a larger pool of applicants and invited to present their work. Mentor-mentee
pairs will be formed based on the area of interest, the type of research being done, and the expertise of the
mentor. In addition, several other didactic activities will take place during the program, including a keynote
lecture, a grant writing workshop, a poster session, and a series of lunch tables for networking as well as to
discuss topics relevant to junior investigators. At the end of the meeting, mentor-mentee pairs will determine
career goals for the mentee and will meet virtually every 6 months to discuss the progress of agreed goals and
to discuss any changes in career trajectory. The specific aims of the program are: 1): To identify 12 junior
Hispanic/Latinx investigators interested in mental health research every year and provide them financial
support to attend and present at the ASHP annual meeting; 2) To engage 12 Hispanic/Latinx investigators
every year in mentorship activities during the ASHP conference; 3) To follow up on the outcome of the junior
Hispanic/Latinx investigators in metrics such as peer-reviewed publications, NIH and other agencies grant
support, scientific presentations, and academic advancement; 4) To develop a network of Hispanic/Latinx
mentors and mentees to support the academic advancement of the mentees. We believe that a highly focused
and personalized mentoring program in the context of the ASHP annual meeting will be a great strategy to train
and mentor rising Hispanic/Latinx investigators. We have assembled a group of prominent Hispanic/Latinx
investigators and mentors in the fields of Psychiatry, Psychology, and Social Work, who will not only provide
the best mentorship experience but also serve as role models for junior Hispanic/Latinx investigators.
Therefore, we are confident that this mentoring program will help increase the representation of
Hispanic/Latinx investigators in the workforce.

Public health relevance
Project Narrative There is a significant underrepresentation of Hispanic/Latinx investigators in the research workforce with Hispanics contributing with a 6% of all funded NIH grants, even though Hispanics represent 18% of the total US population. The goal of this application is to create a highly focused, intense, and personalized mentoring program to train 12 junior Hispanic/Latinx students, post-docs and recently hired faculty members. Mentoring and training activities will be conducted during an expanded and enhanced version of the annual meeting of the American Society of Hispanic Psychiatry by a group of mid-career and senior Hispanic/Latinx investigators with a track record in NIH funding.